The Jackson Laboratory Center for Precision Genetics

PROJECT SUMMARY OVERALL
The goal of the JCPG is to deploy our end-to-end pipeline to build, validate and disseminate precision models of
human disease, and to accelerate the development of treatments for patients through advanced preclinical
testing. Our central innovation is our ability to link world-class services efficiently and seamlessly to provide the
best possible model development and preclinical testing pipeline for our partners. Our team includes leadership
with a track record of building resource programs, experienced scientific, program, and project management
staff, and the support of an experienced Bioinformatics Core for data analysis and dissemination. We have made
outstanding progress in developing our Center and executing its goals during In the current funding phase, our
expanded outreach efforts resulted in a growing number of new external project nominations for a diverse range
of disease areas from investigators and patient groups from around the country. We are on track to exceed our
model generation and phenotyping goals, creating alleles that include highly complex alleles with significant
humanization and/or conditional potential. Our preclinical testing portfolio includes a variety of diseases, organ
systems, and therapeutic approaches, with phenotyping and molecular readouts tailored to the characteristics
of each project; our success is reflected in two projects started at JAX that have progressed to clinical trials. Our
Bioinformatics Core developed a JCPG website, nomination portal and algorithms inform our model development
strategies. Dozens of precision, validated models are now available for public distribution through JAX’s well-
established and supported infrastructure. These successes reflect the JCPG’s ability to work effectively with
researchers, clinicians, foundations and families to identify and delineate disease modeling needs and then
create new mouse models that serve their needs. Our Specific Aims for the next phase reflect our ambition to
expand our impact through the translation of human disease discoveries into precise, predictive models of
disease rapidly impact therapeutic development: 1) To optimize and deploy a comprehensive, scalable, and
flexible pipeline for the generation and characterization of precision mouse models of human disease and to
share mouse model resources through the MMRRC. 2) To develop and execute a robust outreach, project
nomination, and project management infrastructure that expands and facilitates access to our Center for
clinicians, researchers, and foundations. 3) To accelerate the development of novel, precision therapeutics by
linking patient data with new precision animal models, executing preclinical testing of novel therapeutics with
networks of collaborative partners. 4) To integrate an analysis and dissemination infrastructure that will facilitate
development of next-generation predictive models, support the integration of outcomes with human disease
phenotypes, and promote data sharing. 5) To integrate our Center with other JAX programs, resources, and
external-facing services to build connections to JAX’s deep expertise in mouse biology while developing a
scalable, financially sustainable model for access to the JCPG.

Public health relevance
PROJECT NARRATIVE OVERALL Although our understanding of the genetic causes of human disease continues to grow, the translation of these discoveries into clinical application remains cumbersome and slow. The goal of the JAX Center for Precision Genetics (JCPG) is to overcome these challenges through the development and preclinical deployment of advanced mouse models of human disease, in support of the biomedical and rare disease communities. Our goal is to transform the process and speed by which human disease discoveries are translated into treatments for patients.